Targeting mediators of oxidative stress to limit hyperinflammatory cell death modalities during Mycobacterium tuberculosis infection

PROJECT SUMMARY
One of the biggest challenges facing the tuberculosis field is the heterogeneity of TB disease presentation. Only
a small percentage of individuals infected with Mycobacterium tuberculosis go on to develop an acute infection.
While several important tuberculosis co-morbidities have been identified (i.e. HIV co-infection, smoking, malnu-
trition, diabetes), we are still unable to accurately predict whether a tuberculosis patient is at high risk for devel-
oping severe disease. For decades, we have understood that the way in which Mtb-infected macrophages die
plays a key role in dictating Mtb outcomes in vivo. Apoptosis, an “immunologically silent” form of cell death is
generally considered anti-bacterial; apoptosis limits bacterial spread and does not release high amounts of im-
munogenic DAMPs and PAMPs. Necrosis, an inflammatory form of cell death, promotes Mtb survival and spread
and elicits harmful immunopathology. One would predict that a tuberculosis patient with macrophages that
are prone to necrosis would be likely to experience severe inflammation in response to Mtb infection.
Our preliminary data demonstrate that a common human SNP in a mitochondrial-associated gene called LRRK2
promotes a new hyperinflammatory type of necrosis in response to Mtb infection. This cell death was dubbed
gasdermin D-mediated necroptosis, as it requires the pore forming protein gasdermin D and results in activa-
tion of RIPK1/RIPK3/MLKL and cell death via necroptosis. This mutation (Lrrk2G2019S) promotes excessive mito-
chondrial reactive oxygen species (mtROS) production and mtROS alone is sufficient to promote gasdermin D-
mediated necroptosis. Building on these findings, this proposal will test the hypothesis that mitochondrial
dysfunction and oxidative stress drive Mtb-infected macrophages to undergo inflammatory forms of cell
death and constitute a new, important “co-morbidity” for tuberculosis patients. The goal of this proposal
is to mechanistically define how oxidative stress promotes pathogenic cell death modalities during Mtb infection
of macrophages and mice. Here, two models of high mtROS will be leveraged (exogenous mtROS via menadi-
one treatment and the human disease-associated SNP Lrrk2G2019S) to mechanistically define how oxidative stress
can repurpose cell death proteins in primary murine macrophages. Aim 1 will investigate the ability of LRRK2
kinase activity to directly activate necroptosome proteins and promote gasdermin D-mediated necroptosis. Aim
2 will define how various cellular stresses license N-GSDMD association with mitochondrial phospholipids to
promote gasdermin D-mediated necroptosis. Aim 3 will examine the role of lipid oxidation in dictating cell death
modality usage during Mtb infection. If successful, this proposal will define the cellular triggers of hyperinflam-
matory cell death during Mtb infection of macrophages and identify novel points for therapeutic intervention that
may be more efficacious to target in TB patients with underlying conditions or genetics linked to mitochondrial
dysfunction and oxidative stress.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis (Mtb) is an exquisitely evolved, incredibly successful, and difficult to treat human pathogen that currently infects one-quarter of the world’s population. We discovered that during Mtb infection of macrophages, mitochondrial reactive oxygen species (ROS) licenses a necrotic cell death pathway that promotes hyperinflammation and poor disease outcomes. We predict that blocking this newly described cell death pathway may benefit tuberculosis patients with underlying genetics or conditions that are associated with ROS accumulation.